Use of NMNAT chaperone activity against Alzheimer related proteinpathy.

PROJECT SUMMARY
Alzheimer's disease is a progressive, irreversible neurological disorder that slowly destroys the ability to live
independently by affecting memory and thinking skills. While few treatments currently help with some
symptoms, no interventions have yet been demonstrated to delay the onset or slow the progression.
Alzheimer's symptoms are caused by loss of neurons and synapses in the cerebral cortex and subcortical
regions, zones where two neuropathological signs have been found: neurofibrillary tangles and Amyloid
plaques. Neurofibrillary tangles and amyloid plaques are toxic protein aggregates mainly composed
respectively by hyperphosphorylated Tau and amyloid fragment Aβ that cause cell death and
neurodegeneration. One of the keys to reduce the neurodegeneration happening in Alzheimer's patients is to
prevent or block the formation of these aggregates.
NMNAT is an endogenous enzyme involved in cellular metabolism that is known for its neuroprotective
functions, in particular in axon degeneration. Recently, it has been shown that NMNAT can protect cells from
protein-aggregates-induced neurotoxic stress by acting as a chaperone. Chaperones are endogenous proteins
responsible for the re-folding or degradation of misfolded proteins.
The long term goal of this project is to investigate if NMNAT neuroprotective activity can be used in the
treatment of Alzheimer's disease. The objective of this proposal is to determine if overexpression of NMNAT in
two different animal models of Alzheimer's disease can delay or prevent the formation of neurofibrillary tangles
and amyloid plaques. The central hypothesis of this study is that NMNAT chaperone activity is conserved
throughout species and that it can be used in the proteinopathy aspect of Alzheimer's. Guided by promising
data that showed NMNAT preventing the neurodegeneration caused by Tau in a drosophila model, our central
hypothesis will be tested by pursuing two specific aims: (1) Determine if NMNAT has neuroprotective activity in
Drosophila models of Alzheimer's Disease and (2) Determine if NMNAT has neuroprotective activity in a
mouse model of Alzheimer's Disease.
The rationale for the proposed research is that the results will make a lasting impact in the understanding of
neuroprotective pathways that can lead to the treatment of Alzheimer's disease. The proposed research is
therefore relevant to the mission of the NIA “to support and conduct genetic, biological, clinical, behavioral,
social, and economic research related to the aging process, diseases and conditions associated with aging”
and to the current priority of NIA to “Improve our understanding of Alzheimer's disease, other dementias of
aging, and the aging brain”.

Public health relevance
PROJECT NARRATIVE The proposed work will elucidate a novel mechanism of neuroprotection of NMNAT in Alzheimer's disease. This study will determine if NMNAT neuroprotective function is conserved in different species, and if it can be exploited in the treatment of protein aggregates typically found in patients' brains. As a major expected outcome, this research will identify new targets for therapeutic options of Alzheimer's disease.